INTELLECTUAL PROPERTY CONSULTING SERVICE for Contraception Research

The Contraception Research Branch (CRB) of the Eunice Kennedy Shriver National Institute of Child Health and Human Development (NICHD) has the goal to promote contraceptive research and development to prevent or reduce unintended pregnancies.
The purpose of this contract is to provide Program with consulting services (e.g., opinions) for the betterment of a given contraceptive research program. The services are responsive to a need identified by the Contraception Research Branch (CRB) to review intellectual property related materials and make informed decisions on identified funded research (e.g., grants and/or contracts).
The Contractor shall provide consulting services for NICHD CRB including but not limited to the following:
• Provide an opinion to NICHD staff regarding method of use claims related to a grant proposal or service request that discusses an active pharmaceutical ingredient (e.g., small molecule, biological or biosimilar compound) as a potential product.
• Novelty search, as requested by NICHD staff.